Improved therapeutic approaches for hematological disorder treated with tyrosine

DESCRIPTION (provided by applicant): Chronic myeloid leukemia (CML) is a hematopoietic stem cell disorder and currently treated by BCR/ABL tyrosine kinase inhibitors such as Imatinib, Dasatinib and Nilotinib. Clinical relapses are common and pose great challenge for successful tyrosine kinase inhibitor (TKI) therapy. Mutations in the ABL kinase domain are the principal mechanism of Imatinib resistance (IMR). The second-generation BCR/ABL inhibitors Nilotinib and Dasatinib effectively inhibit IMR variants, but are ineffective against the gatekeeper mutant, T315I. Mutation of the gatekeeper residue mediates broad-spectrum drug resistance and is a common mechanism of resistance across tyrosine kinase inhibitor therapy such as ABL, KIT, SRC, PDGFRA, PDGFRB and EGFR. Recently, we have characterized the gatekeeper mutations in these kinases and discovered that the substitution of a bulky hydrophobic residue for the gatekeeper threonine activates the kinase by stabilizing the hydrophobic spine assembled during the active state. We proposed that the next-generation inhibitor should disrupt the assembly of active state and stabilize the inactive state. This work has led us to develop third-generation ABL kinase inhibitors, AP24163, AP24534 and GNF-5. Given our data and experiences with first and second-generation inhibitors, it is likely that resistance to third-generation inhibitors will develop as well. Recently we have shown that the third-generation inhibitor AP24163 - the parent compound of the clinical agent AP24534 - specifically selects for compound mutations in ABL kinase to which we do not have any therapeutic option. This proposal is aimed to identify drug resistant mutations against third generation clinical inhibitors AP24534 (Ponatinib). Compound mutations are mostly presented from the allosteric sites of the ABL kinase. This proposal is aimed to study the mechanism employed by the compound mutations to confer resistance and to develop strategies to target the allosteric sites by small molecule allosteric inhibitors. Towards this end we have identified a unique hydrophobic module- hydrophobic girdle-that governs kinase regulation. We anticipate that a detail characterization of this hydrophobic-motif will help us in developing new allosteric inhibitors tha can be used in combination with ATP- competitive inhibitors to suppress all forms resistant mutations. PUBLIC HEALTH RELEVANCE: Protein kinase inhibitor therapy has emerged as one of the most successful strategy for the treatment of cancers. Chronic myeloid leukemia is hematologic malignancy and treated by kinase inhibitors. However, in the course of the clinical use of these inhibitors, many patients relapse and resistant to treatment posed challenge to cure this disease. Point mutations in the kinase domain mostly cause resistant to inhibitors. This proposal is aimed to develop curative therapeutic response in CML using combination of kinase inhibitors targeting catalytic and allosteric sites.

Public health relevance
Protein kinase inhibitor therapy has emerged as one of the most successful strategy for the treatment of cancers. Chronic myeloid leukemia is hematologic malignancy and treated by kinase inhibitors. However, in the course of the clinical use of these inhibitors, many patients relapse and resistant to treatment posed challenge to cure this disease. Point mutations in the kinase domain mostly cause resistant to inhibitors. This proposal is aimed to develop curative therapeutic response in CML using combination of kinase inhibitors targeting catalytic and allosteric sites.